STRUCTURE AND FUNCTION OF ENZYMES INVOLVED IN THE METABO

Polysialic acid is a virulence factor for several bacteria causing meningitis. It is alos present in the developing human brain. This common occurrence along with the poor immunogenicity of this polysaccharide hampers its use as a vaccine. Several enzymes required for the biosynthesis of polysialic acid are also required for sialylation of vertebrate glycoproteins. The objective of this project is to characterize the structure and function of these enzymes and the use of them as tools for understanding sialylation in bacteria and humans. Comparison of the amino acid sequence with of the E. coli CMP-sialic acid synthetase, an essential enzyme in sialylation, with sequences of the enzyme present in other pathogenic bacteria suggest conserved amino acids. Several basic residues have been identified in the amino terminal sequence by site directed mutagenesis as active residue in the E. coli CMP-sialic acid synthetase. These residues have are conserved in all known bacterial CMP-neuAc synthetase enzymes. Kinetic analysis of the E. coli mutant enzymes suggests these residues may play an essential role in the formation of product and the interaction of nucleotide substrate. The homologous enzyme has been purified to homogeniety from bovine pituitary glands.